Obesity, Biomechanics, and Inﬂammation in Osteoarthritis

Summary
Osteoarthritis (OA) is a painful and debilitating disease of the synovial joints, affecting over 27 million
people in the United States. The prevalence of obesity has risen dramatically in the past two decades,
and we now know that obesity is likely to be the primary preventable risk factor for OA. The goal of this
project is to examine the influence of dietary fatty acids in obesity-associated OA in mice, and to examine
their interaction with altered biomechanical and pro-inflammatory factors using various in vivo and in vitro
models. We propose that low-grade chronic systemic inflammation — due to obesity or pro-inflammatory
fatty acids in the diet — acts in synergy with local inflammatory cytokines or altered mechanical loading
following injury to promote a state of inflammation and matrix degradation in the articular cartilage. In Aim
1, we will examine the role of a high-fat diet rich in omega-6 fatty acids in the development of OA, and we
will examine the effects of endogenous conversion of omega-6 to omega-3 fatty acids to mitigate OA
severity in the Fat-1 transgenic mouse. In Aim 2, we will examine the effects of systemic or local gene
therapy using the Fat-1 gene to mitigate obesity-induced OA. In Aim 3, we will use controlled in vitro
models of cartilage explant loading to examine the effects of mechanical stress in combination with pro-
inflammatory cytokines and fatty acids on the anabolic and catabolic activities of the chondrocytes.
Detailed studies of the interactions between specific dietary composition, pro-inflammatory mediators,
and tissue metabolism in articular cartilage will improve our understanding of the pathology of the OA,
particularly as it relates in vivo to biomechanical factors such as obesity or injury. The results of this
study will provide new insights into key elements of the pathogenesis of obesity-induced, and ultimately
could lead to new treatments that exploit dietary or gene therapies to prevent disease.
!
!

Public health relevance
Narrative The goal of this project is to examine the influence of dietary fatty acids on obesity-associated osteoarthritis in mice, and to examine their interaction with altered biomechanical and pro-inflammatory cytokines using various in vivo and in vitro models. We will test the hypothesis the genetic conversion of pro-inflammatory omega-6 fatty acids to anti-inflammatory omega-3 fatty acids will mitigate the severity of obesity-induced osteoarthritis.